INITIAL SCREENING FOR HEALTHY VOLUNTEERS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This purpose of this study to screen and assess individuals, ages 12 to 85, wishing to participate as healthy volunteers in any psychiatric studies at the Zucker Hillside Hospital.